Effects of Prior Exposure to Conflicting Health Information on Responses to Subsequent Unrelated Health Messages

PROJECT SUMMARY/ABSTRACT Many population-level public health strategies rely on messaging to promote cancer prevention and control. These strategies do not take place in a vacuum; rather, they occur in the context of a broader public information environment, which is increasingly characterized by conflicting and often controversial health information. Although studies have documented that such information is prevalent, a critical question remains unanswered: does exposure to conflicting health information in people's routine interactions with the broader information environment threaten the success of message-based population-level public health strategies? And, if so, who is most susceptible to the effects of such exposure? These are questions that cannot be ignored, given the substantial investments made in such strategies, including the estimated $2.2-$2.6 billion that NIH spends every year on behavioral interventions to prevent cancer and other chronic diseases. The proposed study will provide a rigorous empirical test of these critical answered questions, guided by two specific aims: First, to evaluate whether prior exposure to conflicting health information influences responses to subsequent unrelated and uncontested health messages, a phenomenon that has been described as “carryover effects” (Primary Aim); and second, to identify whether there are individual-level differences in how conflict affects responses to these unrelated and uncontested health messages (Secondary Aim). To accomplish these aims, an online survey-based experiment using a population-based sample of U.S. adults (N=~1400) will be conducted. At 3 time points across a 3-week period, participants will be exposed to real news stories about several health topics (e.g., nutrition, mammography, HPV vaccine). Participants will be randomized to 1 of 2 treatment groups that differ only in the amount of conflict presented in these news stories (high conflict, no conflict). After the 3-week period, all participants will be exposed to unrelated messages about behaviors for which there is scientific consensus (e.g., skin cancer prevention). To assess carryover effects, cognitive, affective, and behavioral intentional responses to these messages (e.g., attitudes toward and interest in sun-protective behaviors) will be measured. These messages are expected to be less effective among those who were randomized to receive conflicting health information. Individual-level differences in the pattern of these responses are also expected, with carryover effects of exposure to conflict being more pronounced among certain groups (e.g., those with greater trust in media sources, those of lower socioeconomic position). Using an innovative research design, the proposed project will directly assess whether the broader information environment, with its ubiquitous conflicting health messages, undermines the success of message-based population-level public health strategies.

Public health relevance
PROJECT NARRATIVE Many population-level public health strategies—including media campaigns and other behavioral interventions, screening recommendations, and vaccination policies—rely on messaging in their efforts to promote cancer prevention and control. The goal of the proposed study is to determine whether current public health messaging strategies are vulnerable to pervasive conflicting health information in the broader public information environment. Knowledge generated by this study will guide interventions to minimize the adverse effects of conflicting health information and, in turn, increase the likelihood that public health messaging strategies will be successful.